Dissecting roles of Lunatic Fringe-dependent Notch signaling in pancreatic cancer

Despite improvements in overall survival for most cancers, survival for patients with pancreatic
cancer remains dismally low due to the late diagnosis and rapid spreading. Understanding
pancreatic cancer initiation and progression is of great importance for the development of effective
intervention strategy. Mouse models recapitulating human pancreatic ductal adenocarcinoma
(PDAC) have been generated through activation of oncogenic Kras combined with various genetic
mutations in different pancreatic cell types, and studies using mouse genetics suggest that both
acinar and ductal cells can give rise to PDAC, and cellular origins and specific gene mutations
may determine the precursor lesion initiation, progression, as well as molecular subtype of PDAC.
Notch signaling pathway is a master regulator of cell fate decision and differentiation critical for
pancreatic development and is dysregulated in pancreatic cancer. We recently discovered that
expression of a Notch modulator, Lunatic Fringe (Lfng), is confined to a subset of centroacinar
cells in the normal pancreas. Lfng-expressing centroacinar cells are uniquely susceptible to
oncogenic transformation and deletion of Lfng blocks tumor initiation from these cells. Lfng is
upregulated in acinar and ductal cell-derived precursor lesions, and deletion of Lfng decelerates
tumor development from these two cell types. Thus, Lfng exerts oncogenic roles in the
development of PDAC from three distinct cellular origins: centroacinar, acinar and ductal cells.
Amplification and upregulation of LFNG are noted in human PDAC and are associated with poor
survival. Therefore, we propose to dissect roles of Lfng-dependent Notch signaling in pancreatic
cancer using multiple approaches including organoid culture, lineage tracing, temporal and
lineage-specific genetic manipulations, differential gene expression analysis, as well as functional
analysis of candidate genes in human PDAC cell lines to address the following Specific Aims: 1)
determine roles of Lfng-dependent Notch signaling in pancreatic cancer development from Lfng-
expressing centroacinar cells; 2) determine roles of Lfng-dependent Notch signaling in acinar- and
ductal-derived PDAC pathogenesis; and 3) characterize Lfng-expressing pancreatic cancer cells
and identify genes differentially expressed in these cells as potential therapeutic targets.
We hope to demonstrate that Lfng is critical for the initiation and progression of pancreatic cancers
arising from different cell types of the pancreas, and that Lfng marks pancreatic cancer stem cells
thought to be responsible for drug resistance and cancer relapse. Identification of genes
downstream of Lfng-dependent Notch signaling may lead to the development of biomarkers for
targeted therapy for this particularly deadly disease.

Public health relevance
Despite improvements in overall survival for most cancers, survival for patients with pancreatic cancer remains dismally low. This project aims to address the cellular origin, initiation and progression of pancreatic ductal adenocarcinoma (PDAC) and to identify genes and signals critically involved in this process. Successful completion of this project may provide an opportunity for targeted therapy for this devastating disease.